THE IMMUNE SELF-ASSOCIATED STORAGE ORGANELLE (SASO)

PROJECT SUMMARY
This study investigates how the body maintains a memory of ‘Self’. When facing foreign organisms and cancer,
this self-knowledge is thought to be critical, serving to educate the immune system to limit autoimmunity and
conversely license reactivity to things that are ‘Foreign’. The core of the study focuses on a newly-discovered
organelle, found within macrophages and some dendritic cells which we call the Self-Associated Storage
Organelle or SASO for short. We believe that the SASO is critical to ‘hold’ our self-identity and subsequently
educate the rest of our immune system and it appears to come from a stealthy and subtle form of ‘cell
nibbling’.Our proposal is unique in applying cutting technologies—lattice-light sheet imaging, vesicle flow, Mass-
spectrometry and Electron Microscopy—together with conventional cellular immunoassay methods and genetic
screens, to understand how this newly described component of the immune system works as well as how we
can harness it to improve health. The resultant discoveries will be formative for designing new ways to boost
anti-tumor immunity, to minimize autoimmunity and to broadly regulate which components of our bodies are seen
as ‘Self’.

Public health relevance
PROJECT NARRATIVE The proposed research is will discover how our bodies come to know the difference between our own cells (our ‘Self’) and foreign organisms and genes. The project will allow us to better teach the immune system which things to attack and which to leave alone, thus enhancing health, lengthening life and reducing illness.